Immune responses in traumatic RGC death

? DESCRIPTION (provided by applicant): Traumatic injuries of the nervous system, such as traumatic brain injury (TBI), spinal cord injury (SCI) and traumatic optic neuropathy (TON), are major causes of death and disability in the USA and major challenges for the healthcare of veterans. In addition to the primary injury, secondary injuries, which occur after the primary injury dramatically worsens the damage and cause about 40% of TBI deaths. Because little can be done to reverse the primary injury, the primary aim of the treatment is to prevent secondary injury induced neuronal death. One of the major secondary injuries of TBI, SCI and TON is glutamate excitotoxicity, the pathological process by which neurons are damaged and eventually killed by excessive stimulation of glutamate receptors. Therefore, effectively minimizing or preventing glutamate excitotoxicity will reduce the secondary injury to neurons. In addition, glutamate excitotoxicity also plays critical roles in many other neurodegenerative diseases, such as glaucoma, the leading cause of blindness in the world, including veteran population. Both TON and glaucoma specifically injure retinal ganglion cells (RGCs). Because RGCs are the only cells relaying the visual signals from the eyes to the brain, loss of RGCs will result in an irreversible loss of vision and no effective treatments are currently available. Therefore, preventing RGCs from death in TON and glaucoma is crucial to preserve vision. Understanding the mechanisms which control the vulnerability of RGCs to glutamate excitotoxicity, TON or glaucoma will help us to develop treatment strategies to prevent RGC death in these diseases. Recent studies have shown that immune molecules play important roles in neuron repair and cell death in CNS diseases. In the retina, the receptors of major histocompatibility complex (MHC) class I molecules, T-cell receptor, (TCR) and their associated proteins are expressed by RGCs. Mutation of these molecules compromised RGC dendrite and axon structure and increased the vulnerability of RGCs to glutamate excitotoxicity while up-regulated MHCI expression in motor neurons significantly promoted the recovery of locomotor abilities after SCI. These findings strongly support the possibility that MHCI/TCR could protect RGCs from death. In this study, we plan to characterize the vulnerability of RGCs to glutamate excitotoxicity and optic nerve crush (ONC), investigate the roles of TCR in the regulation of RGC vulnerability, and determine the therapeutic potential of activation of TCR for the prevention of RGC death. The first goal of this study is to determine the contribution of a key molecule of TCR, CD3ζ, to the vulnerability of RGCs. Our preliminary results showed that different subtypes of RGCs have different vulnerability to glutamate excitotoxicity and RGC vulnerability to glutamate excitotoxicity is dramatically increased in CD3ζ-/- mice. We will further characterize the vulnerability of four subtypes of RGCs to glutamate excitotoxicity and ONC, and the contribution of CD3ζ?to RGC vulnerability. The second goal is to determine the therapeutic potential of overexpressing CD3ζ to protect RGCs. Our preliminary results demonstrated that expressing CD3ζ in RGCs of CD3ζ-/- retinas restored the RGC dendritic defects, suggesting the reversibility of CD3ζ-mediated effects on RGCs. We plan to further determine whether the resistance of RGCs can be enhanced by over-expressing the gene encoding CD3ζ. The third goal of this study is to determine the therapeutic potentials of CD3ζ activating molecules to protect RGCs. It has been demonstrated that CD3ζ could be activated by exogenous CD3ζ activating molecules in vitro. We will further determine if the exogenous CD3ζ?activating molecules work synergistically with the over-expression of CD3ζ to protect RGCs. Overall, this study will identify the role of MHCI-TCR in the regulation of the vulnerability of RGCs to pathological insults, and test the potential of using MHCI/TCR mediated mechanisms to protect RGCs from death in diseases. Although RGCs are used as a model in this study, the results could provide important insights into the neuronal death of other areas of CNS and, therefore, have important implications in neuronal protection following traumatic injuries in the CNS.

Public health relevance
PUBLIC HEALTH RELEVANCE: Glutamate excitotoxicity plays a central role in the neuronal death induced by traumatic brain injury (TBI) and traumatic optic neuropathy (TON), which are major challenges faced by the VA healthcare system. Because retinal ganglion cells (RGCs) are the only cells which relay the visual signals from the eyes to the brain, and they are vulnerable to TON or brain disorders, loss of RGCs will result in irreversible loss of vision and no effective treatments are currently available. Therefore, preventing neuronal death in TBI and TON is crucial to preserve function. This study will characterize the vulnerability of RGCs to glutamate excitotoxicity and TON, investigate the roles of TCR to the vulnerability of RGCs and determine the therapeutic potential of protecting RGC from death by activating TCR in the retina. The results of this study could provide important insights into the protection of neurons in both the retina and CNS following traumatic injuries. Therefore, the experiments proposed in this study will have important implication in developing treatment strategies for VA patients.